Targeting the neural circuits controlling negative reinforcement to prevent alcohol seeking in males and females

ABSTRACT
Alcohol use disorder (AUD) is characterized by high levels of alcohol intake followed by aversive
negative affective states when individuals cease consumption. In certain individuals suffering from
AUD, alcohol taking and seeking is, in many cases, thought to be motivated by negative
reinforcement, where individuals continue consuming alcohol to avoid these negative internal states
that are triggered by abstinence. While a large body of work has outlined the precise brain regions,
cellular populations, and neural circuits that underlie these affective states and their effects on
behavior in rodents and humans, to our knowledge, studies have not explicitly focused on the circuits
controlling negative reinforcement itself – the action of avoiding aversive stimuli. Recent work from
our group has shown that there are robust sex differences in negative reinforcement behavior at
baseline. Moving forward, it will be critical to understand if there are sex differences in the circuits that
control negative reinforcement and if alcohol-induced alterations in these circuits interact with
biological sex to alter AUD. We focus on the role of medium spiny neurons (MSNs) in the nucleus
accumbens (NAc) as our preliminary data show that manipulations of D1 receptor containing MSNs in
the NAc causally mediate negative reinforcement. Additionally, previous work has shown that this
cellular population can alter drinking and alcohol seeking and undergoes robust plasticity following
alcohol consumption. Thus, D1 MSNs causally mediate negative reinforcement, are altered by
alcohol consumption, and are capable of triggering alcohol seeking. We hypothesize that binge
alcohol exposure enhances negative reinforcement by altering medium spiny neurons in the
NAc on the circuit and molecular level, and that basal sex differences interact with alcohol-
induced alterations in these systems. Using operant tasks where animals emit operant responses
to avoid negative outcomes, we will 1. Use in vivo microendoscopy to outline the cell-type specific
neural activity signatures that underlie negative reinforcement in males and females 2. Determine
how these signatures are changed by alcohol exposure and abstinence in males and females and 3.
Determine molecular effectors within these populations in both sexes using cell-type specific
transcriptional profiling. Together, the Vanderbilt Alcohol Research and Education Center (VAREC)
allows for an integration of research aimed at collaboratively answering how AUD-associated
phenotypes emerge using precision neuroscience approaches.